Mechanism of Medication Overuse Headache and Chronic Migraine Pain

DESCRIPTION (provided by applicant): Migraine, perhaps the most common neurological condition, is a debilitating disorder characterized by episodic pain and other symptoms (i.e., nausea, vomiting, photophobia or phonophobia with or without aura). While the pathophysiology of this disorder remains unknown, an important theory suggests that migraine may occur as a consequence of cortical spreading depression (CSD). Migraine, and perhaps CSD events, may be precipitated by a variety of triggers including stress and provocative chemical agents such as donors of nitric oxide (NO). Migraine is often treated with triptan drugs which are effective in some patients but which are also associated with an increase in the incidence of headache frequency, i.e., medication overuse headache. We reasoned that transformation of episodic headaches into MOH, and perhaps CM, by triptans may result, in part, from medication-induced neural adaptations that enhance responses to stimuli that can trigger migraine attacks (i.e., migraine triggers). For this reason, we hypothesize that a period of triptan exposure results in persistent hypersensitivity to migraine triggers that are associated with increased cortical spreading depression (CSD) events and activation of primary afferent fibers that innervate the dura. Three specific aims test this hypothesis. First, are enhanced behavioral and neurochemical responses observed in rats pre-exposed to a period of triptan treatment accompanied by spontaneous (i.e., non-evoked) or increased CSD events following an evoking stimulus? (Aim 1); second, do the persistent pronociceptive changes elicited in dural primary afferent neurons by triptans result in subsequent activation and potentially increased excitability of dural afferent neurons in response to stimuli known to promote migraine attack in humans or after a CSD event? (Aim 2); and third, what are the roles of nNOS and CGRP in promoting enhanced sensitivity to migraine triggers, and/or CSD events and excitation of dural afferents? (Aim 3). A significant problem in preclinical efforts to study migraine mechanisms and pain is that animal models of headache generally require induction of tissue injury whereas migraineurs suffer from pain in the absence of injury (i.e., dysfunctional pain). Our approach mimics the human state by inducing neural adaptations using medications without causing tissue injury. Our goal is to use the triptan-induced sensitized state to investigate possible mechanisms underlying MOH and by which episodic pain may transform into CM. Critically, the events that may promote enhanced pain signaling following challenge of rats with latent sensitization with migraine triggers are also likely to yield insights into mechanisms relevant to pathophysiological states of underlying migraine. The data from the proposed experiments will result in mechanistic insights that can be tested clinically.

Public health relevance
PUBLIC HEALTH RELEVANCE: Migraine is one of the most common neurological disorders. This condition is often treated with triptan drugs. However, overuse of these mechanisms may elicit transformation of episodic migraine to chronic migraine. The mechanisms underlying "chronification of pain" are not known but may be related to changes in threshold to respond to triggers of migraine. Understanding such mechanisms may give insight into underlying pathophysiology of medication overuse headache and chronic migraine and of migraine pathophysiology. Project Narrative: Migraine is one of the most common neurological disorders. This condition is often treated with triptan drugs. However, overuse of these mechanisms may elicit transformation of episodic migraine to chronic migraine. The mechanisms underlying "chronification of pain" are not known but may be related to changes in threshold to respond to triggers of migraine. Understanding such mechanisms may give insight into underlying pathophysiology of medication overuse headache and chronic migraine and of migraine pathophysiology. __SpecificAimsTextDelimiter__ Specific Aims: Migraine is an episodic multi-symptom disorder characterized by cephalic pain and often associated symptoms such as aura, nausea, vomiting, and extreme sensitivity to light, sound or movement. The mechanisms responsible for this disorder are poorly understood. Trigeminovascular-mediated central sensitization has been invoked as a partial explanation for pain as well as other symptoms including, especially, cutaneous allodynia (CA). CA has been observed in most, but not all, patients during migraine with distribution that can include both cephalic and extra-cephalic territories5. Central sensitization, the presumed underlying physiological substrate of CA, is believed to underlie the progression of migraine pain, the relative resistance to triptan medications, and possibly the transformation from an episodic to a chronic, more disabling disorder known as chronic migraine (CM)6-7. Triptans are thought to relieve headache pain by inhibiting the release of pronociceptive transmitters through actions on 5HT1B/1D receptors on trigeminal afferent neurons.8 However, overuse of triptans can lead to increased frequency of migraine attacks in individuals with migraine, a phenomenon termed medication overuse headache (MOH)9-11. Thus, triptans elicit important therapeutic actions but additionally can produce maladaptive actions that elicit and increase the occurrence of migraine upon repeated use, and promote chronic migraine (CM), characterized by headache on more than 15 days per month9-11. We reasoned that treating animals with triptans might elicit maladaptive actions that could induce a "migrainous state", offering opportunities to explore the biology of migraine and of MOH/CM. Intermittent, or continuous, triptan administration to rats over a period of days indeed results in a state of "latent sensitization" (LS) that persists long after discontinuation of drug. Triptan-induced LS is characterized by persistent increased labeling for CGRP and nNOS in identified trigeminal ganglion (TG) cells innervating the dura and enhanced sensitivity to presumed triggers of migraine attack (i.e., NO donor; stress). Rats with LS show baseline (i.e., normal) sensory thresholds but develop cephalic and extracephalic CA following challenge with NO donor or stress and increased levels of CGRP in the blood following challenge with NO donor1. An important theory suggests that migraine attack may occur as a consequence of cortical spreading depression (CSD)12. CSD may activate and sensitize primary afferent neurons innervating the dura mater resulting in sensitization of second-order neurons in the trigeminal nucleus caudalis (TNC) and higher brain centers, to cause cephalic/extracephalic CA8. Chronic triptan exposure may increase the incidence of CSD events, or consequence of CSDs, to initiate signaling in the trigeminovascular system to enhance the frequency of migraine headaches. Our preliminary data indicate that triptan treated rats show increased CSD events following exposure to environmental stress and these rats (but not controls) are allodynic following induction of CSD. Clinically, migraine aura often (but not always) precedes a migraine attack and CSD events are widely thought to be potential initiators of a migraine attack. Thus, these findings are consistent with the possibility that triptan treatment induces persistent excitatory neural adaptations that may have translational relevance to migraine and the evolution of episodic migraine to MOH and CM. While a genetic basis has been proposed for migraineurs, Olesen and colleagues have shown that migraine headache can be induced in non- migraineurs13. Non-migraineurs, however, require higher doses or longer exposure to the provocative agent13 suggesting that (a) a genetic predisposition is not essential to experience a migraine, and (b) an important difference between migraineurs and non-migraineurs may be that the former have lower threshold (i.e., an enhanced response) to stimuli that may "trigger" migraine attacks in normal daily life (e.g., stress). Thus, transformation of episodic migraine into MOH or CM by triptan overuse may result, in part, from medication- induced neural adaptations that enhance responses to "migraine triggers". We hypothesize that triptan exposure results in persistent hypersensitivity to migraine triggers. Due to this hypersensitivity, migraine triggers could result in (a) increased CSD events; (b) CSD- induced activation of dural afferents or (c) increased excitability of primary afferent and second-order neurons independent of CSD events. Three specific questions will be addressed by the experiments proposed in this application. First, do the enhanced behavioral (i.e., CA) and neurochemical (i.e., blood CGRP) responses observed in rats with triptan-induced latent sensitization result as a consequence of spontaneous (i.e., non-evoked) or evoked CSD events (Specific Aim 1)? Second, do the persistent maladaptative changes elicited in dural primary afferent neurons by triptans increase the likelihood of their activation in response to CSD events or migraine triggers (Specific Aim 2)? Third, do nNOS and CGRP promote enhanced sensitivity to migraine triggers, and to CSD events and excitation of dural afferents (Specific Aim 3)?